PREVENTION OF EARLY OCCLUSION AND INFECTION IN PRESSURE EQUALIZATION TUBES

To assess the efficacy and appropriateness of sulfonamide ear drops in preventing early occlusion and infection of pressure equalization (PE) tubes.